Clinical validation of NS-0200, a fixed combination drug product for the treatment of hypertension

PROJECT SUMMARY
Hypertension is a major cause of premature death globally, responsible for 10.4 million deaths annually. Around
1.28 billion adults aged between 30-79 worldwide have hypertension, of which only 1 in 5 adults (21%) have it
under control. Hypertension is diagnosed when blood pressure (BP) is consistently ≥130 (systolic BP (SBP))
and/or ≥80 mmHg (diastolic BP (DBP)). It is associated with both an increased risk of cardiovascular disease
(CVD) and reduced life expectancy. The prescribed first line of hypertension drugs belongs to the thiazide
diuretics, calcium antagonists, angiotensin converting enzyme (ACE) and angiotensin receptor blockers (ARB)
classes of drugs. Other diuretics and beta blockers are considered secondary either due to safety and tolerability
issues or due to weaker clinical outcomes. According to the American Heart Association (AHA) and the American
College of Cardiology (ACC) 2018 hypertension guidelines, the on-treatment target BP is <130/80 mmHg. In
general, at least 2 antihypertensive drugs with different mechanisms of action are required to achieve proper BP
control. However, in spite of the multiple classes of drugs, efficient BP control is only achieved in 30.4% of treated
adults. NuSirt Sciences, Inc. (NuSirt) developed a fixed dose combination (FDC) of L-leucine, metformin and
sildenafil (NS-0200) as a hypertensive drug with potential to improve other cardiometabolic risk factors
(bodyweight (BW), hyperlipidemia and glycemic control). L-leucine with low doses of metformin and sildenafil
activates the Sirt1/AMPK/eNOS energy metabolism pathway thereby modulating Sirt1-dependent metabolism
and serving as a partial mimetic of calorie restriction on BP regulation. In the present SBIR Phase II project,
NuSirt will manufacture NS-0200 under GMP conditions to conduct a 12-week randomized clinical trial on
hypertensive adults to determine the efficacy of the drug in controlling BP compared to placebo. Primary endpoint
analysis will be the evaluation of change in mean seated SBP from baseline to study termination. Secondary
endpoint analysis will comprise the evaluation of change in DBP and body weight. Exploratory analysis will
consist of assessing the effect of NS-0200 on blood glucose and lipid levels. Safety will be assessed throughout
the study by examination of adverse events (AE), concomitant medications, clinical laboratory evaluations, vital
signs, physical examinations and 12-lead ECGs. Completion of this SBIR Phase II will serve as a foundation to
pursue a Phase III clinical program, aiming to compare the efficacy of NS-0200 with other hypertension drugs
currently available in the market.

Public health relevance
PROJECT NARRATIVE Hypertension is a primary risk factor for cardiovascular disease (CVD), including stroke, heart attack, heart failure and aneurysm, which is mostly undetected due to lack of noticeable symptoms. In spite of the different classes of antihypertensive drugs available, only 21% of adults with hypertension in the US have their BP under control. NuSirt’s drug combination NS-0200 will be the first anti-hypertensive drug modulating energy metabolism, mimicking the effect of calorie restriction on BP regulation and reducing the risks of developing cardiometabolic symptoms.